2025 Stress Proteins in Growth, Development and Disease Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
Protein homeostasis (often referred to as proteostasis) is the equilibrium in our cells between the timely making
and degradation of proteins to ensure function and to avoid accumulation of toxic species. Both the continuously
changing normal physiology and a manifold of external challenges, including acute forms of stress (temperature,
oxidation and inflammation) or chronic conditions (expression proteins from inherited gene mutations or due to
somatic mutations during aging) require a highly orchestrated and versatile protein quality control systems that
ensures that this balance is well-maintained. This network not only concerns chaperones and protein degradation
systems (both proteasomal and lysosomal) that assist in folding and disposal, but also coordinated regulation of
the making or halting of protein synthesis (both at the transcriptional and translational level). Importantly, if protein
homeostasis collapses, a progressive cascade of protein aggregation is initiated driving the age-related decline
in cellular functions and degeneration of tissues, ultimately leading to loss of organismal resilience. Whilst protein
aggregation is best known as the driver of neurodegenerative diseases, it is becoming clear that it is also a root
cause for several other age-related diseases including cardiomyopathies, muscular dystrophies and type-2
diabetes. Inversely, the adaptive capacity of cells to restore imbalances in the making of (faulty) proteins by
adjusting their protein quality control systems sustains their vitality during carcinogenesis. The 2025 GRC on
"Stress Proteins in Growth, Development and Disease", scheduled for July 6-11, 2025, at the Jordan Hotel at
Sunday River. This 12th installment will be held under the subtitle “Targeting the integrated PQC network to
combat ageing and age-related diseases” and promises to cover the cutting edge advances in the field of protein
homeostasis, ranging from the basic regulatory mechanisms that drive their versatile and adaptive response to
changing conditions, to how components of protein quality control systems act at the molecular level to handle
(misfolded) proteins, up to (pharmacological) intervention strategies that boost or inhibit these systems to combat
(age-related) diseases to improve healthy aging. The conference will begin with the Graduate Research Seminar
(GRS) on July 5-6, nurturing the next generation of investigators in our field. Exceptional GRS participants,
selected by the GRS attendees, will showcase their research through oral presentations at the main conference.
Moreover, dedicated sessions and roundtable discussions will empower junior investigators, emphasizing
inclusivity and diversity in scientific pursuits. Finally, a PowerHour session, focused on diversity, will complete
this conference. Our meetings have always blended cutting-edge science, on a deeper understanding of the
maintenance of protein homeostasis, with a warm and inclusive atmosphere, fostering collaborations and
invaluable connections for future careers. Led by Dr. Harm H. Kampinga (chair) and Dr. Patricija van Oosten-
Hawl (co-chair), this GRC promises to uphold its reputation as a premier gathering in the field, charting the
course for future advancements in protein homeostasis research.

Public health relevance
PROJECT NARRATIVE The function and health cells, tissues, and organisms rely heavily on maintaining the delicate protein balance (protein homeostasis), adjusting the cellular protein make-up to both external and internal changes. Especially with age this balance can become impaired, leading to degenerative conditions like neurodegenerative and (cardio)muscular diseases. This conference aims to enhance our understanding of the crucial systems regulating protein homeostasis to sustain health and how they get derailed during human aging and illness and provide valuable training and networking opportunities for students and early-career researchers.